Examining precursors to language impairment in ASD via remote assessment

Project Summary/Abstract
Roughly 30% of autistic individuals remain minimally verbal as adults, often despite significant intervention. This
is due, in part, to our limited understanding of the mechanisms underlying language development in autistic
children. This gap in our knowledge is attributable to the developmental gap between the onset of language
development in infancy and the diagnosis of autism in late toddlerhood. To better understand early development
in autism, researchers often study infant-siblings of diagnosed children as the rate of diagnosis in this population
is roughly 20%. To draw meaningful conclusions about a population as heterogeneous as autistic children, large
samples are required. To date, the need for in-person assessments has made it challenging to collect the
requisite sample to understand how language develops in infants who go on to develop autism. This R21
proposal takes the first steps to overcoming these challenges and moving closer to the NIDCD Strategic Goal of
identifying and developing interventions targeted to specific populations. To do this, we will leverage recent
advances in the remote administration of looking time tasks for infants and automated coding of infant looking
behaviors. Our group recently established the feasibility of remote assessment of cognitive development using
a scalable battery of remote tasks and computer vision software to reliably identify gaze direction in response to
these tasks administered on home computers. Here we extend this work to test three posited mechanisms of
language impairment in autism: (1) Atypical Speech Perception; (2) Audiovisual Synchrony Processing, and (3)
Prediction. This project will identify robust tasks for assessing these skills remotely and pilot this approach in
infant siblings of autistic children. With the information gained from this study, we will assess the relative
contribution of these mechanisms for language development in autism, thereby improving our capacity to design
targeted interventions that can improve quality of life for autistic children and their families.

Public health relevance
Project Narrative This project will establish robust tasks for assessing mechanisms related to language impairment in autism during infancy, before a clinical diagnosis can be made. This work extends recent efforts in our group to establish a remote and scalable battery of tasks for the assessment of cognitive development in this population. Valid and robust measures of cognitive and language development that are scalable to large populations of infants will allow us to gather the critical information we need for future development of targeted interventions in a population as heterogeneous as children with autism.